DEVELOPMENT OF AMIDINES AS SELECTIVE MUSCARINIC AGONISTS

Research in our laboratory focuses on the development of novel muscarinic agonists for the treatment of neurological disorders, including Alzheimer[unreadable]s disease and chronic pain. Characterization of new compounds requires mass spectral data analysis, and our laboratory depends heavily on the MSU Facility for help with structure determination and verification.